Role of HNF4alpha in Liver Regeneration

Project Summary Hepatocyte nuclear factor 4 alpha (HNF4α) is considered the master regulator of hepatic differentiation because of its ability to regulate several hepatocyte specific genes. Recent studies from our group and others have revealed that HNF4α can inhibit hepatocyte proliferation and maintains adult hepatocyte quiescence. Our studies show that deletion of HNF4α in mature adult liver (HNF4α-KO mice) results in spontaneous hepatocyte proliferation with hepatomegaly without any tissue damage or injury. Further, HNF4α-KO mice demonstrate increased liver cancers. However, the mechanisms of HNF4α-induced inhibition of hepatocyte proliferation are not known. Preliminary data obtained using combinatorial RNAseq-ChIPseq analysis of HNF4α-KO livers indicate that HNF4α inhibits several promitogenic genes in quiescent hepatocytes both via direct histone deacetylation-mediated epigenetic regulation. Based on these data we hypothesize that HFN4α inhibits hepatocyte proliferation by inhibition of promitogenic gene expression via epigenetic mchanisms. Similarly, the role of HNF4α in liver regeneration, a process critical for liver homeostasis and which involves controlled proliferation of differentiated hepatocytes, is not known. Preliminary studies show that HFN4α expression and activity decline dramatically within first 12 hr after partial hepatectomy (PH) in mice and returns back to pre-PH levels at day 5 after PH. Decline in HNF4α activity coincides with initiation of cell cycle and return of HNF4α activity coincides with termination of liver regeneration. Further, we observed a termination/redifferetiation defect in HNF4α-KO mice after PH, which exhibited continued cell proliferation even at 7 days after PH. Based on these data we hypothesize that HNF4α reprograming is critical for both initiation and termination of liver regeneration. The studies proposed in this grant application will determine the previously unknown role of HNF4α in regulation of hepatocyte proliferation in normal and regenerating livers. These studies will demonstrate that HFN4α is a critical player in liver regeneration and could be a novel therapeutic target for regenerative therapies in various liver diseases including acute liver failure and liver cancer.

Public health relevance
Project Narrative The main goal of this project is to determine the role of HNF4 in regulation of hepatocyte proliferation during liver regeneration. The objectives of this grant are to determine the mechanisms by which HNF4 maintains quiescence in mature hepatocytes and the role of HNF4 in initiation and termination of liver regeneration.